Benefit of Venetoclax Addition ("Benefit VA") in Chronic Lymphocytic Leukemia/Small Lymphocytic Lymphoma (CLL/SLL)

Chronic lymphocytic leukemia/small lymphocytic lymphoma (CLL/SLL) is an incurable, prevalent B-cell
malignancy. Inhibitors of Bruton’s tyrosine kinase (BTKi) are commonly used oral therapies used to treat
CLL/SLL and are continued indefinitely, but can cause toxicities, symptoms, and impaired quality of life (QoL) in
a significant subset of patients. Since BTKi have modest responses, there drugs are used continuously. Long-
term therapy with BTKi exposes patients to its long-term toxicities, thereby compromising patient experience
during continuous therapy. CLL/SLL and its optimal therapy is of particular interest to the Veterans
Administration (VA) because of the higher incidence of CLL/SLL in Veterans and its relationship with Agent
Orange. CLL/SLL patients are interested in initial therapy that is easy to take, has a fixed duration, effectively
treats the CLL/SLL, minimizes long-term toxicities, and improves symptoms and QoL. Our overall goal is to care
for Veterans with CLL/SLL in an evidence-based patient-centric approach. Our central hypothesis is that in
CLL/SLL patients, who are already receiving initial therapy with and responding to BTKi, the addition of
Venetoclax (Ven) and then discontinuation of both medications after one year will lead to increase in the depth
of response measured as minimal residual disease (MRD) and will improve patient’s experience, as compared
to those patients receiving BTKi alone. In the proposed phase II, multi-site clinical trial in Veterans with
CLL/SLL, patients will be randomized 1:1 to either continue BTKi (arm A) alone or to continue BTKi at the
same dose and to initiate Ven ramp up per the manufacturer’s label (arm B). Patients on arm A will continue
BTKi for three years, whereas patients on arm B, BTKi and Ven will be discontinued after 12 cycles. Patients
will be recruited from hematology-oncology VA clinics across the US, and the study will allow for a decentralized
research process to maximize Veteran access to this study. Eligible patients will have measurable disease and
belong to the low tumor lysis syndrome (TLS) risk group. In arm B (investigational arm), consenting patients will
continue on a 28-day cycle with the BTKi they are already receiving, at the same dose, and will add Ven with the
standard ramp-up dosing in cycle one, and then continue full dose thereafter. After 12 cycles of combination
therapy, both BTKi and Ven will be discontinued, and patients will enter long-term follow up. The primary
objective is to compare disease response between the two arms by measuring minimal residual disease in the
blood (primary outcome). The secondary objectives are to measure patient experience through patient
reported outcomes, assessment of cancer symptoms (measured by VSAS), QoL (measured by EORTC QLQ-
C30, QLQ-CLL17), financial toxicity (measured by FACIT-COST), adverse events (CTCAE v5.0), and overall
response rates, progression-free and overall survival. Patient demographic and CLL/SLL molecular risk factors
will be collected to evaluate their association with the objectives. The results of this study will inform best
practices for treating CLL/SLL patients, focusing on optimizing the patient experience while providing highly
effective therapy. The VA is uniquely poised to perform this study, demonstrating potential benefits to Veterans
and potential long-term medication cost savings to the health-care system.

Public health relevance
Chronic lymphocytic leukemia/small lymphocytic lymphoma (CLL/SLL) is a cancer of white blood cells that is incurable but treatable. One of the most common treatments is Bruton Tyrosine Kinase (BTK) inhibitors, pills taken continuously. This study focuses on Veterans with CLL/SLL currently treated with BTKi. The study will evaluate whether continuous BTKi therapy versus adding venetoclax, another oral CLL/SLL therapy, to BTKi for one year and then discontinuing both medications will ultimately improve clinical and patient-reported responses, measured by established protocols to capture the depth of response and also fatigue, other cancer- related symptoms, quality of life (QoL), and toxicities. Information focusing on the patient experience and the effectiveness of therapy will be collected. This study will help doctors better treat CLL/SLL patients, help improve QoL and symptoms and allow therapy discontinuation safely and effectively.